ROLE OF PARENTAL GUIDANCE IN PEDIATRIC ASTHMA SELF MANAGEMENT IN INNER CITY

This study is to examines the relationship between parental guidance behaviors and asthmatic children's adherence to physician recommended medicine regimen and assumption of responsibility for asthma self-management, in an urban minority population.